HIV and Drug Abuse Prevention Research Ethics Training Institute

PROJECT SUMMARY
The global HIV/AIDS pandemic, shifts in drug use patterns, and advances in intervention research designs, all create new
ethical challenges for studies at the intersection of HIV and drug abuse. To date, there is a paucity of well-qualified
investigators trained to conduct scientifically rigorous studies to inform policies directed at meeting these challenges. The
goal of this renewal is to advance the contributions of the Fordham University HIV and Drug Abuse Prevention Research
Ethics Training Institute (RETI), the only program of its kind, to meet this need. The broad long-term objectives of the
RETI are to train a new generation of scientists who will conduct robust and unbiased designs to inform research ethics
practices sensitive to the unique needs of individuals with and at-risk for HIV and substance abuse and to extend the
program's global impact through online scientific and pedagogical resources. These objectives are met through the
following aims. Aim 1: To increase early career clinical scientists' capacity to conduct rigorous and reproducible
empirical research on HIV and drug abuse prevention research ethics practices and policies. Ethical decisions by
investigators and IRBs/RECs are often guided by subjective interpretations of broadly worded regulations and guidelines.
Empirical data on ethics practices and policies is thus needed to better inform these decisions. Aim 1 will address this
need through the RETI mentored research project (MRP), a multi-year funded research experience in which trainees
receive intensive supervised experience designing, implementing, analyzing and disseminating an original study on HIV
and drug abuse research ethics. The MRP will be conducted in conjunction with the annual RETI Summer Institute that
will build trainee competencies in the unique conceptual frameworks and research designs for conducting studies on
research ethics. Aim 1 will also be achieved through career development activities designed to enhance publication and
grant writing skills and to disseminate trainees' work through a new public webinar series. Aim 2: To increase early
career clinical scientists' capacity to engage communities in the construction of HIV and drug abuse participant
protections. Although community advisory boards (CABs) are now commonplace in HIV and drug abuse research, few
programs teach trainees how to involve appropriate stakeholders in the development of the study design and the
procedures to protect participant rights and welfare. This has often led to limited empowerment of prospective participants
as collaborative partners. Aim 2 will be achieved through Summer Institute seminars on methods to engage prospective
participants in ethics-relevant dialogue and inclusion of community advisory boards at the design and interpretation stages
of the mentored research project. Aim 3: To create and sustain a global information network for enhancing ethical
knowledge and evidence-based ethics practices, policies and pedagogy for HIV and drug abuse prevention research ethics.
Aim 3 will be achieved through expansion of RETI's global online HIV and drug abuse research ethics scientific and
pedagogical resources. As a new feature, the RETI will promote transformative partnerships between investigators and
communities by creating Community Access to Research Ethics (CARE), a social media platform specifically tailored to
bring research ethics science to communities and populations represented in HIV and drug abuse research.

Public health relevance
Project Narrative The burden of HIV/AIDS falls hardest on people who inject or use drugs, who are often among a nation’s poorest, most disempowered and stigmatized populations. To date, there is a paucity of well-qualified scientists with the unique investigative skills required to inform research ethics decision-making to adequately protect the rights and welfare of these vulnerable populations. Through its intensive summer training program, funded mentored research experience, and public online resources, the Fordham University HIV and Drug Abuse Prevention Research Ethics Training Institute will provide early-stage clinical scientists with the competencies to address the global need for empirical and educational resources to inform research ethics practices and policies involving persons with or at-risk for HIV and drug addiction.